miRNA site-blocking ASOs as MeCP2 targeted therapeutics

SUMMARY
An emerging theme in neurodevelopmental research is that both loss of function and overexpression of
the same pathogenic gene can result in autism-associated phenotypes. For many disorders, such precise
requirements for protein dosage have complicated what was once thought to be a linear path to gene therapy.
This challenge is epitomized by Rett syndrome, a monogenic neurodevelopmental disorder caused by loss of
function mutations in a methyl-reader known as Methyl-CpG Binding Protein 2 (MeCP2). On the surface, RTT
appears to be an ideal candidate for gene therapy; however, targeting MeCP2 itself with traditional gene
replacement strategies is complicated by a stringent requirement for protein dosage, whereby even a 1-fold
increase over neurotypical levels evokes adverse effects. The practical challenge created by these narrow
dosage requirements is that, not only does viral MeCP2 delivery need to be efficient across the entire human
brain, but each must cell receive roughly the same, relatively small amount. One endogenous mechanism used
to fine-tune MeCP2 expression is via microRNA (miRNA) regulation of its 3’untranslated region (UTR). As the
contribution of each miRNA to MeCP2 expression is modest by nature, we hypothesized that preventing the
binding of repressive-miRNAs would be a viable approach to increase MeCP2 dosage, yet remain within its
narrow safety margins. To test this hypothesis, we developed locked nucleic acid (LNA) site blocking (sb) ASOs
designed to outcompete mir-22, mir-132, and mir-483 for binding to the MeCP2 3’UTR. In support of our
hypothesis, increasing concentrations of each ASO in vitro resulted in increasing amounts of MeCP2 protein to
a point that plateaued at a 0.75 to 4-fold increase, depending on the miRNA site being blocked. We contend that
this approach is ideally suited for patients with common missense or late-truncating mutations, where some
function is preserved and where overexpression of the mutant protein is known to improve phenotypes in mice.
In patients, eight MeCP2 mutations are responsible for 70% of all RTT cases, and five of these are missense
and late-truncating, potentially suggesting a broad utility. In Aim 1, we will use fibroblast and iPSC-derived
neurons from RTT patients to determine the subpopulations where overexpression of the mutant protein
demonstrates efficacy. In Aim 2, we will use osmotic micropumps to deliver a dose-response of each sbASO to
Mecp2T158M/y mice and establish a therapeutic range for efficacy and adverse effects. The T158M mouse model
was chosen because transgenic overexpression of the mutant allele has already been shown to be effective at
improving phenotypes. In recent years, advancements in ASO chemistry have removed many of the long-
standing barriers preventing their clinical development. Here we propose that LNA-modified ASOs designed to
outcompete endogenous miRNA for MeCP2 regulation are a viable therapeutic approach for RTT patients with
missense or late-truncating mutations.

Public health relevance
NARRATIVE Monogenic neurodevelopmental disorders like Rett syndrome appear to be ideal candidates for gene therapy; however, targeting the causative gene (methyl-CpG binding protein 2, MeCP2) itself with traditional gene replacement strategies is complicated by a stringent requirement for protein dosage. Here we propose that the administration of locked nucleic acid (LNA)-modified antisense oligonucleotides (ASOs) designed to outcompete endogenous repressive-miRNA for regulation of the MeCP2 3’untranslated region is a viable therapeutic approach for RTT patients with missense or late-truncating mutations. Our preliminary support this theory, as mir-22, mir-132, and mir-483 site-blocking ASOs increase MeCP2 expression in a dose-dependent manner which is capped at subtoxic levels by the relatively modest contribution of each endogenous miRNA to MeCP2 regulation.